Neural and behavioral predictors of cognitive development and internalizing problems in adolescents with autism spectrum disorder

ABSTRACT:
Adolescence is a period of strong cortical plasticity accompanied by significant changes in cognitive, social,
and adaptive functioning. Despite the promise characteristic of this period, it is also a time when social
relationships and emotion processing may intensify, and depression and other forms of psychopathology first
emerge. The lack of longitudinal studies of adolescents with autism spectrum disorder (ASD), coupled with the
disorder's heterogeneity, clouds our understanding of development during this complex period, and hinders
treatment development. We thus propose to extend our longitudinal investigation of children from the UC Davis
MIND Institute Autism Phenome Project cohort into adolescence. In Specific Aim #1, we predict aspects of
cognitive development in adolescents with ASD based on grant period studies. We hypothesize that ASD will
continue to exhibit at least three trajectories of intellectual functioning (IQ) -- a group with persistently below
average IQs (< 75) from early childhood through adolescence (Persistently Low or P-Low), a group with IQs <
75 in early childhood that increase by at least 1 standard deviation by adolescence (Positive Changers or
+CHG), and a group with persistently average or better IQs (>75) (Persistently High or P-High). We also
predict that preparatory cognitive control will continue to be comparable to TYP, but will be associated with
behavioral inflexibility; that all groups will exhibit comparable performance on aspects of episodic memory; and
that P-Low will show fewer negative emotional false memories. In Specific Aim #2, we examine social
awareness, motivation, and adaptive functioning in between middle childhood and adolescence in ASD. We
predict that +CHG will show improved social awareness and functioning compared to P-Low and P-High,
while all groups show declining social motivation, and that resting state functional magnetic resonance imaging
functional connectivity (FC) between the executive/cognitive control (ECN), default mode (DMN), and salience
(SN) networks will be predictive of adolescent social awareness and social functioning while social motivation
is predicted by concurrent engagement of the striatum. Specific Aim #3 investigates the emergence of
depression in ASD between middle childhood and adolescence. We test a prominent model predicting that
increased depression between middle childhood and adolescence will be more common in P-High and +CHG,
and will be associated with increased social awareness, greater retention of negative emotional memories, and
less flexible cognitive control. Additionally, we predict that during a well-validated task-based fMRI Sadness
Introspection Paradigm, functional connectivity between the ECN, DMN, SN, amygdala, and hippocampus
during sadness introspection will be associated with adolescent depression in P-High and +CHG. We also
predict that parent questionnaires, compared to gold standard clinician interviews, will under-report depression
in P-Low. This longitudinal examination of cognition, social functioning, and depression in adolescents with
ASD holds the potential to identify early markers of depression and more tailored precision medicine solutions.

Public health relevance
Project Narrative We use behavioral and neuroimaging measurements to extend our longitudinal investigation of children from the UC Davis MIND Institute Autism Phenome Project cohort into adolescence, with a focus on examining cognition, social functioning, and the emergence of depression in individuals with three phenotypes of intellectual functioning (IQ) from early childhood to adolescence—one with persistent intellectual disability (ID) (P-Low); one with persistently average or better IQs (P-High); and one with IQs improving from the ID to the average or better range (+CHG). We predict that P-Low will exhibit strengths in episodic memory, and low levels of depression, although we investigate whether this is a result of under-reporting; that P-High, while cognitively able, will experience the highest levels of depression; and that +CHG will show strongest cognitive and social development without some of the liabilities experienced by P-High.